Vivarium Core

Vivarium Core
Summary
The objective of this core is to support the operations of the Vivarium facility
at Delaware State University and ensure that it provides both efficient operations to
support the research of COBRE investigators at DSU and high quality care for our
rodent research subjects. The research of several faculty members supported by the
Phase I and Phase II COBRE awards depends on the operation of the vivarium for husbandry of mouse models for
their research. Our COBRE Vivarium core will provide support and staff to maintain operations of our new rodent
housing facility which was renovated with support from our Phase I COBRE grant, and which became fully
operational in early 2017. COBRE support for the Vivarium Core at DSU will maintain the animal care staff
including animal care technician, a facility manager and partial support for a veterinarian, so that the facility can
provide outstanding animal care for COBRE-affiliated researchers to increase their research productivity. As the
level of funding for faculty research grows eventually the facility can be sustained by charges to faculty research
grants.
We also propose to purchase and install the Tecniplast DVC® (Digital Ventilated Caging) complete system
in the Vivarium. The complete system allows for 24/7 monitoring of food and water levels, as embedded sensors
into the lateral runners detect the presence of food and water bottles cage by cage. The system evaluates bedding
conditions and identifies when cages need to be changed reducing running costs, avoiding unnecessary animal
handling, and providing 24/7 detection of unexpected water floods due to mishaps with water bottles. The round-
the-clock animal activity detection allows for continuous animal welfare information, and since vital animal
parameters (drinking, feeding, anomalies in locomotor activity) can be detected remotely, it will reduce the
personnel entering the animal facilities. Real-time monitoring the environmental parameters and cage characteristics
will also add precision to the timing of cage changes and other care-taking activities, reducing the need for staff
time.
With automated 24/7 tracking of the status of the cage environment and animal activity, the DVC system
significantly improves animal welfare and facility efficiency and productivity, while providing researchers with a
unique data stream that can improve the translational potential of their animal models. Continuation of the COBRE-
supported Vivarium core will significantly advance the research program of COBRE investigators and help DSU
recruit outstanding candidates for future faculty openings.

Public health relevance
Delaware Center for Neuroscience Research Public Health Relevance Summary The foundation of Phase III proposal is Delaware’s expanding set of human and research resources in neuroscience, which has Delaware neuroscience research competitive on a national level. Our project supports research aimed at determining how thoughts, memories, feelings and actions emerge from dynamic activities in the brain and are changed over time; as well educational programs to develop a workforce that can participate in and benefit from advances in our understanding of brain function. An increased understanding of how the brain and nervous system functions will facilitate treatments for diseases and injuries and provide insights into human behavior, biases, and cognition.